RFA-DP-24-138, Connections for Health: Centering school connection and health for rural young people

Abstract
Connections for Health: Centering school connection and health for rural young people. Rural areas in the
United States have higher rates of poverty and lower access to healthcare, including mental health services.
Adolescents in rural areas are at higher risk for alcohol, tobacco, and other substance use, pregnancy, and
sexually transmitted infections, yet often have diminished access to appropriate services. Comprehensive
health education (CHE) that includes social, emotional, and sexual health has shown promise in improving
health behaviors among adolescents in general, but the provision of health education may be hindered by
a lack of financial and staffing resources in rural schools. The gap in resources and the unique needs and
challenges regarding rural adolescent health indicate a need for CHE in schools adapted for rural context.
Additionally, rural educators also face unique challenges, such as the impact of rural poverty and trauma
on students, limited exposure by their students to a diverse group of peers, and greater scrutiny by the
school board, local churches, and the community in general, which signify the need for professional
development and attention to teacher wellness. Yet rural school districts face challenges with providing
professional development for educators due to problems with funding as well as teacher recruitment and
retention. The overarching goal of this project is to address health inequities among rural young people and
improve the health and mental health of adolescents in rural schools. Our proposed approach, to be tested
in a quasi-experimental design involving 14 rural high schools in a Mid-Atlantic state, includes key strategies
core to CDC’s What Works in Schools: 1) an evidence-informed, skills-based comprehensive health
education program (HealthSmart) that also addresses social and emotional and sexual health, and
tailored to the needs of rural communities; and 2) a comprehensive professional development program
to support teachers in addressing the complex needs of rural students and their own wellness. The project
offers a number of innovations, including: • school and community input on the health education needs of
rural youth and the program components; • online microskill modeling resources for educators to strengthen
implementation quality within the sexual health unit; • professional development workshops to build capacity
to effectively deliver the health curriculum, and to increase inclusion and students' sense of school belonging
(especially for youth of color and LGBTQ+ youth) • a focus on teacher wellness to prevent workplace
stress/burnout; • addressing gaps in the implementation science literature regarding school-based health
promotion in rural settings; and • community-driven practices using science-based and equity frameworks.

Public health relevance
Project Narrative Connections for Health: Centering school connection and health for rural young people project is designed to address health inequities among rural young people through school-based health education. The two major components of the project are: 1) an evidence-informed, skills-based comprehensive health education program that is tailored to the needs of rural communities and addresses social and emotional skill development in addition to health and sexual health; and 2) a comprehensive professional development program that supports teachers in addressing the complex needs of rural students and supports their own wellness. This project will help build the evidence base for school-based strategies that promote the health and well-being of rural young people.